Telehealth CBT to increase engagement in pain treatment among Veterans using prescription opioids

Background: Chronic pain and negative consequences of long-term opioid therapy are related public health
concerns associated with significant functional impairment, high psychiatric comorbidity, and premature
mortality, particularly among Veterans. Clinical Practice Guidelines for opioid prescribing and pain
management recommend using non-pharmacological approaches as first-line treatments. Psychosocial
interventions (e.g., cognitive-behavioral therapy) have strong evidence supporting their ability to improve pain
outcomes. Patient beliefs about the stigma associated with psychological interventions, opioid analgesics,
ability of psychosocial intervention to improve pain among others can greatly interfere with the patients’ ability
to initiate and maintain engagement in psychosocial interventions and other non-pharmacological approaches.
Significance/Impact: Without a concerted effort at affecting beliefs that impede engagement in treatment,
Veterans who may benefit from the treatment, will not receive it. This can result in continued risk for negative
consequences associated with long-term opioid therapy and inadequate pain management. Cognitive-
Behavioral Therapy for Treatment Seeking (CBT-TS) is an evidence-based intervention that directly intervenes
on beliefs that act as barriers to treatment initiation and retention. By intervening on these beliefs, this study
has the potential to improve engagement in psychosocial pain interventions and other non-pharmacological
pain treatments, which will improve pain-related interference and functioning and reduce reliance on opioid
analgesics. This study addresses VHA/VA Veteran care priorities including opioid use, pain management, and
access and directly addresses priorities of the HSR&D Targeted Solicitation for Service Directed Research on
Opioid Safety and Opioid Use Disorder.
Innovation: The proposed study is the first application of CBT-TS for Veterans with chronic pain who are
receiving opioid analgesics–a notably high-risk, treatment-resistant population. This is the first study to directly
intervene on thoughts about psychosocial interventions.
Specific Aims: The specific aims are to: test the effects of CBT-TS to increase initiation of psychosocial
interventions for pain among Veterans receiving opioid analgesics for chronic pain (Aim 1), test the effects of
CBT-TS to increase the retention in psychosocial interventions for pain among Veterans receiving opioid
analgesics for chronic pain (Aim 2), and evaluate the effects of CBT-TS in improving pain and substance use
outcomes among Veterans receiving opioid analgesics for chronic pain (Aim 3). We will also test the effects of
CBT-TS on the initiation of and retention to other non-pharmacological pain treatments (Exploratory Aim).
Methodology: Participants (N = 300) will be randomized to either the CBT-TS condition or an education
control condition. Participants in both conditions will complete assessments on pain, treatment engagement,
and opioid use at baseline, and 1-, 3-, and 6-months post-treatment to assess primary, secondary, and
exploratory outcomes.
Implementation/Next Steps: Results from this study will provide critical information on increasing
engagement of psychosocial interventions for pain, which can be used to inform future implementation and
dissemination efforts. The research team will work with the VHA National Pain Management and Opioid Safety
office and the VHA Office of Patient Centered Care & Cultural Transformation to identify implementation and
dissemination efforts. CBT-TS is undergoing current implementation research to increase mental health
functioning and this effort could be expanded to also increase treatment engagement of psychosocial
interventions for pain and other non-pharmacological pain treatments.

Public health relevance
According to Clinical Practice Guidelines, psychosocial interventions for pain are recommended as first-line treatments to manage pain, yet barriers to care, including patient beliefs, interfere with initiation of such treatments. The proposed study uses a cognitive-behavioral intervention to target beliefs to increase the initiation and engagement in psychosocial interventions for pain among Veterans using prescription opioids. This study will test the effects of this evidence-based intervention on increasing treatment initiation of and retention to psychosocial interventions for pain and the subsequent effects on pain and substance use outcomes.